Community Outreach and Engagement

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
COMMUNITY OUTREACH AND ENGAGEMENT - PROJECT SUMMARY/ABSTRACT
The overarching goal of the MECC Community Outreach and Engagement (COE) is to promote health equity
and reduce disparities in cancer-related health outcomes in our Bronx catchment area (CA). More than 85% of
patients who come to MECC for cancer care reside in this CA. The Bronx is a community of nearly 1.5 million
residents, with 55% Hispanic/Latinx, 33% Black, 14% White, and 34% identifying with two or more races. Bronx
residents are 35% foreign-born and 26% report difficulty with English. The Bronx is designated as a persistent
poverty county with over 24% of residents living at or below the poverty level. The case mix of patients that come
to MECC reflects this diversity. Cancer incidence in the Bronx is strongly associated with neighborhood poverty.
As such, COE focuses on addressing social determinants of health in partnership with the community.
Our specific aims are to: 1) Define, assess, and monitor cancer burden in the Bronx CA; 2) Develop, implement,
and evaluate the impact of strategies to address the cancer burden; 3) Foster and facilitate catchment area-
relevant research within all MECC Research Programs; 4) Enhance enrollment of underrepresented patients in
clinical trials; and 5) Share lessons learned through dissemination to advance cancer health equity
The MECC COE is led by Bruce Rapkin, PhD, Associate Director for COE. MECC’s COE efforts are built upon
exceptionally strong relationships with community and health system partners. COE activities span the cancer
continuum, from prevention and early detection to treatment to survivorship and supportive care. The COE team
consists of project coordinators, data managers, and community outreach specialists, along with cancer patient
advocates and pre-med interns. COE partners with community, clinic and public health sectors to leverage
established programs and relationships. COE strategies are conceived and guided by a Community Advisory
Board (CAB), COE liaisons from MECC Research Programs, and MECC Senior Leadership to ensure alignment
of action, research, policy and practice. Our Learning Health Care Community logic model fosters on-going data-
driven decision-making and problem-solving among these multiple stakeholders. Ongoing needs assessments
provide direction and iterative feedback on metrics of success. Disseminating MECC research outcomes is
intrinsic to the process. By addressing cancer equity in the broader context of social determinants through
community partnerships, we have been able to arrive at solutions that are making a real difference in our CA.
COE seeks to continue to expand and innovate as we work to become a national model for reducing cancer
incidence and disparities in diverse populations.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward COMMUNITY OUTREACH AND ENGAGEMENT - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page